EXERCISE TRAINING, BODY COMPOSITION, GH, AND LEPTIN IN OVERWEIGHT CHILDREN

We have studied the effects of exercise on body composition and weight loss in moderately obese children. We expect that exercise will be as effective as a cognitive program (Shapedown).